Functional and Structural Optical Coherence Tomography for Glaucoma

PROJECT SUMMARY
Glaucoma is a leading cause of blindness in the US. The management of glaucoma is based on early
detection, followed by careful evaluation and monitoring to identify those with rapid disease progression and
high risk for vision loss. This allows for the rational use of medical, laser, and surgical treatments. Current
methods of assessing glaucoma have significant limitations. Visual field (VF) testing has a low sensitivity for
detecting early disease, and its reproducibility worsens in advanced stages, reducing its reliability for
monitoring disease progression. Optical coherence tomography (OCT) precisely measure the peripapillary
nerve fiber layer (NFL) thickness and is the most commonly used technology for objective glaucoma
evaluation. However, NFL thickness has limited sensitivity in detecting early glaucoma, and reaches a floor
value in moderate glaucoma, which prevents it from tracking glaucoma progress into later stages. The goal of
the proposed research is to develop advanced OCT technology that will enhance detection of early glaucoma,
improve the sensitivity of detecting significant disease progression, and increase the accuracy of measuring
progression speed. The Specific Aims are:
1. Develop a directional high-resolution OCT and OCT angiography prototype to improve imaging of
structure and perfusion. The prototype will have real-time control of beam direction to maintain
perpendicular incidence on the NFL for accurate reflectance analysis, which has shown promise for very
sensitive detection of early glaucoma. Sensorless adaptive-optics aberration correction will enable high
transverse resolution to enhance the detection of nerve fiber bundle and capillary defects. Ultrahigh axial
resolution will enable assessment of the pentalaminar structure of the inner plexiform layer.
2. Wide-field OCT and OCT angiography analyses and visual field simulation. Wide peripapillary and
macular scans, using a next-generation commercial spectral-domain OCT system, will allow visualization of
nerve fiber and perfusion defects from the disc margin to temporal raphe, thus improving early glaucoma
detection. VF simulation will be performed to convert OCTA perfusion measurement to a VF-equivlaent dB-
scale familiar to clinicians for monitoring progression. The simulation has higher reproducibility than actual
VF, which improves detection of disease progression and measurement of progression speed.
3. Clinical studies in glaucoma diagnosis and monitoring. The clinical study will test whether the
proposed new technologies can improve the detection of pre-perimetric glaucoma, detection of disease
progression, and the accuracy of measuring the speed of progression.
This research is likely to transform the clinical practice of glaucoma by developing novel objective functional
and structural tests that can be practically implemented on the next generation of clinical OCT systems. This
will save vision by achieving accurate diagnosis in early glacuoma and timely intervention in rapid progressors.

Public health relevance
PROJECT NARRATIVE Optical coherence tomography (OCT) is a high-resolution imaging technology that is already commonly used to diagnose and monitor glaucoma, a leading cause of blindness. The proposed research will further improve this technology so that it can detect earlier stages of glaucoma, evaluate the location and severity of glaucoma damage, and provide more accurate monitoring of disease progression. Directional OCT technology will be developed to accurately measure nerve fiber layer reflectance; sensorless adaptive-optics OCT technology will be used to improve imaging of nerve fiber bundles and capillaries; ultrahigh axial resolution will enable imaging of detailed internal retinal structures such as the lamellae of the inner plexiform layer; and capillary perfusion measurements will be used to simulate visual field function.